Submicron-Resolution Integrated Spatial Transcriptomics and Proteomics for Studying Kidney Disease

ABSTRACT
Kidney diseases, including chronic kidney disease (CKD), acute kidney injury, and glomerulonephritis, impact
nearly 850 million people worldwide, leading to significant morbidity, mortality, and rising healthcare costs. While
spatial transcriptomics has offered valuable insights by mapping gene expression within specific kidney niches,
a comprehensive understanding of kidney disease requires spatial multiomics approaches that can detect both
RNA and protein at single-cell or subcellular resolution. However, current spatial omics technologies struggle to
analyze the kidney's complex structure and diverse cell types, and integrating RNA and protein assays at high
resolution remains both technically challenging and costly. The overall goal of this project is to address these
limitations by optimizing Pixel-seqV2, a submicron-resolution spatial transcriptomics assay, and developing
ProteoPixel-seq for integrated co-profiling of transcriptomes and proteomes in human kidney disease. Building
on Pixel-seqV1, which uses 1-µm-resolution "polony gels", as capture DNA arrays for spatial RNA sequencing,
we will enhance its resolution to 0.6 µm through a scalable "polony gel stamping" method, reducing the array
fabrication cost by over 100-fold. In Aim 1, Pixel-seqV2 will be optimized for spatial transcriptomics of the kidney
at single-cell resolution. Sub-Aim 1A focuses on integrating 0.6-µm-resolution polony gels and optimizing assay
conditions to improve RNA capture sensitivity and spatial resolution, while Sub-Aim 1B involves applying the
optimized assay to both mouse and human kidney samples, refining cell segmentation algorithms to accurately
delineate complex cell boundaries and detect rare, pathologically relevant cell populations. In Aim 2, ProteoPixel-
seq will be developed for integrated spatial co-profiling of transcriptomes and proteomes. Sub-Aim 2A aims to
expand Pixel-seqV2 with high-plex proteomic analysis using DNA-tagged antibodies, optimizing tissue assay
conditions for simultaneous RNA and protein detection. In Sub-Aim 2B, we will apply ProteoPixel-seq to CKD
patient biopsy samples, focusing on interactions between kidney stroma and infiltrating immune cells to reveal
molecular pathways involved in disease progression and identify potential therapeutic targets. This project will
yield catalytic tools for spatial multiomics tissue mapping, offering the first demonstration of integrated spatial
transcriptomics and proteomics in kidney disease, significantly enhancing our understanding of kidney pathology
and supporting the development of novel diagnostics and therapeutics.

Public health relevance
NARRATIVE Kidney diseases affect millions of people worldwide, leading to high rates of illness and death, as well as rising healthcare costs. This project aims to develop advanced technologies that can map both gene and protein activity in kidney tissue at single-cell resolution, providing deeper insights into the molecular mechanisms of kidney diseases. By improving our ability to study how different cell types interact in the diseased kidney, this research has the potential to enhance early diagnosis, guide new treatments, and ultimately reduce the burden of kidney disease.